Tailoring Neural Transplants for Cervical Spinal Cord Repair

PROJECT SUMMARY/ABSTRACT
Stem cell technologies offer new promise for some of the most devastating medical conditions that currently lack
treatments. To harness the full therapeutic potential of stem cells, however, it will be necessary to understand
how to direct their differentiation to appropriate cell phenotypes, understand how they may change with in vitro
manipulation, and how the external milieu may influence their fidelity after transplantation into injured or diseased
host networks. These gaps in knowledge are the cornerstones of my long-term training plan. My research goal
is to become an independent scientist pursuing translationally relevant research. To do so, I will build upon my
technical in vitro skills from undergraduate research, and now use a model of pre-clinical spinal cord injury as a
testbed for my hypotheses regarding the therapeutic potential of transplanted engineered cells. More than half
of all spinal cord injuries occur at the cervical level resulting in major respiratory deficits and complications. These
deficits are largely due to the disruption of descending bulbospinal respiratory pathways and damage to spinal
respiratory motor circuits. While current therapies are aimed at enhancing the plasticity of spared networks, they
fail to treat the underlying cause of deficits: neural loss. One promising strategy for neural repair is the use of
cellular transplants, yet very little is known about their phenotype, development, and connectivity to host
networks after transplantation. Importantly, even less is known about how these cells change with each
manipulation in vitro (e.g., addition of growth factors, how cryopreservation may change the phenotypic potential,
etc.). Neural precursor cells (NPCs) have been used for decades to repair the injured central nervous system.
However, these donor cell populations are highly heterogeneous, have not been well characterized and
preparation of these cells for transplantation may further alter their heterogeneity. A primary goal of the present
study is to address this issue and enhance their therapeutic potential by enriching for specific subsets of spinal
interneurons known to contribute to beneficial plasticity and repair. The current proposal will test the therapeutic
potential of refined populations of donor NPCs, enriched with pre-motor V0 spinal interneurons, to promote
anatomical (Aim 1) and functional (Aim 2) improvement post-SCI.

Public health relevance
PROJECT NARRATIVE There are currently almost 300,000 Americans living with spinal cord injury, 60% of which occur at the cervical (neck) level disrupting the phrenic motor network and impairing breathing, leading to life-threatening complications. Transplantation of neuronal precursor cells has shown promise to promote repair and recovery of breathing after cervical spinal cord injury, but the heterogeneity of these cells has generated questions about which types of cells are the most beneficial. The proposed experiments aim to tailor transplantable neural cells to comprise the most beneficial cells types for repair and motor recovery.